Gene Expression Profiling of Primary Human Hepatocyte (PHH) Inter-Individual Variance in Adaptive Stress Response Activation

Abstract: The objective is to utilize technology for mid to high throughput transcriptomic measurement of gene expression changes for a variety of chemical exposure scenarios. Keywords: toxicity, high throughput transcriptomics.